Neurobehavioral and Psychosocial Predictors of Health Risk Behaviors in Adolescence and Young Adulthood

PROJECT SUMMARY
Young adulthood is a developmental period during which health risk behaviors (HRBs) (e.g., substance use)
peak, but the factors that lead to sustained addiction are not well understood. Current neurobiological models of
risk taking focus on a developmental imbalance between the brain’s control and reward systems to explain the
typical heightened risk taking seen in adolescence. We have shown that the two systems involved in value-
based decision making—i.e., the valuation system (risk and reward processing) and the control system (cognitive
control)—predict HRBs in adolescence. However, patterns of brain development during adolescence that predict
continuity vs. discontinuity in HRBs in young adulthood are unknown. To fill these significant gaps, we will
conduct longitudinal analyses to prospectively measure developmental trajectories of neurobehavioral
mechanisms underlying HRBs throughout adolescence and young adulthood, and to characterize psychosocial
risk and resilience factors that influence these developmental trajectories. We propose that poverty, abuse, and
neglect are risk factors that are linked to HRBs through their impact on neurobehavioral mechanisms underlying
HRBs, and that social integration is a resilience factor that deters HRB progression during young adulthood. We
address the following aims: (1) we will assess longitudinal and bidirectional associations between valuation and
control systems and HRBs from adolescence to young adulthood; (2) we will examine whether poverty, abuse,
and neglect (experienced in childhood and adolescence) are associated with young adult HRBs through altered
developmental trajectories of valuation and control systems in adolescence (i.e., neurocognitive vulnerability);
and (3) we will examine whether social integration mediates the link between valuation and control decision-
making systems and HRBs, and moderates the effects of psychosocial stress on HRBs. This application
addresses these aims by extending a prospective longitudinal study to follow up 167 adolescents through young
adulthood (23-27 yrs) who were previously assessed during adolescence (13-22 yrs). Our sample is from
underserved, understudied communities with elevated substance use rates, and thus is well-poised to provide
critical insights about HRBs in at-risk populations. Our intensive longitudinal multiple-level data (11 prospective
measurement occasions over 15 years) will provide an unprecedented opportunity to understand both individual
differences and within-person developmental changes in neurobehavioral mechanisms underlying HRBs from
adolescence to young adulthood. The proposed study will (i) advance developmental theory regarding dynamic
processes of brain-HRB associations; (ii) generate new knowledge regarding how psychosocial risk factors alter
developmental trajectories of neural mechanisms underlying HRBs; and (iii) uncover neurocognitive and social
resilience factors that can be targeted for strategic intervention to prevent HRB progression and addiction.

Public health relevance
PROJECT NARRATIVE The proposed study will examine the contribution of developing neural markers—valuation and control—to substance use throughout adolescence and young adulthood (13-27 years) by following a well-characterized longitudinal sample recruited from understudied and underserved communities that have high rates of substance use and addiction. Thus, the neurobehavioral and psychosocial predictors of health risk behaviors in this cohort may provide important insights about health risk behaviors in this community and other high-risk populations. By clarifying (1) long-term effects between valuation and control decision-making systems and health risk behaviors throughout adolescence and young adulthood and (2) roles of psychosocial risk and resilience factors that influence these mechanisms, the proposed study will yield critical information for identifying youth with high neurobiological vulnerability for developing substance use disorders. The findings will further inform ways of designing optimally-timed, targeted prevention efforts to ameliorate developmental pathways of youth who are at risk for substance misuse and addiction.